Host-pathogen interactions controlling Chlamydia developmental cycle

SUMMARY
Chlamydia trachomatis is the leading cause of sexually transmitted infections of bacterial origin. No vaccine is
available. Infections are often asymptomatic, leading to long-term damage of the reproductive organs and
deleterious effects on human health ranging from pelvic inflammatory disease to infertility. Pathogenesis is linked
to a host inflammatory response triggered by the invasion of the genital tract epithelium with this obligate
intracellular pathogen. A hallmark and critical aspect of Chlamydia intracellular life style is its bi-phasic
developmental cycle, during which the bacteria alternate between infectious (EB) and replicative (RB) forms
within the lumen of a membrane-bound compartment called the inclusion. The mechanisms that govern
progression through the developmental cycle are poorly understood. Here we describe a Chlamydia conditional
mutant in an inclusion membrane protein. The mutant displays a severe, yet complementable, developmental
defect in the early stages of the developmental cycle, most likely during EB to RB conversion. Moreover, this Inc
protein interacts with a host factor involved in the late stages of the developmental cycle, when the bacteria exit
the cell via extrusion. We propose to test the hypothesis that this Inc protein plays a dual role early (Aim 1) and
late (Aim2) during the developmental cycle and to determine its contribution to pathogenesis (Aim 3). Through
the use of cell biology, bacterial genetics, transcriptomics, proteomics and in vivo approaches, our studies will
further our understanding of the molecular mechanisms governing the host-Chlamydia interactions that control
the developmental cycle. Altogether our work has the potential to identify therapeutic targets to block
transmission of and pathogenesis associated with this important sexually transmitted pathogen.

Public health relevance
PROJECT NARRATIVE Chlamydia trachomatis is the leading cause of sexually transmitted infection of bacterial origin in the US. Infec- tions are often asymptomatic and, if left untreated, can lead to permanent damage of women’s reproductive organs. Our goal is to elucidate how the bacterium establishes its replication niche and induces pathogenesis.